Learning to Predict Delayed Cerebral Ischemia with Novel Continuous Cerebral Arterial State Index

Project Summary
Delayed cerebral ischemia (DCI) is the most devastating complication after aneurysmal
subarachnoid hemorrhage (aSAH) and has an incidence rate of 30%. Current practice relies on
intermittent assessment of neurological status and daily cerebral blood flow velocity (CBFV) by
Transcranial Doppler ultrasound (TCD) to guide medical management to prevent DCI. Only after
medical management fails, is endovascular treatment (EVT) including intraarterial vasodilator infusion
and/or intracranial angioplasty initiated. This reactive practice does not account for early predictors of
DCI and may miss the optimal EVT window at an early stage of DCI development before symptoms or
severe deviations from normal hemodynamics. The goal of this project is to develop algorithms to
predict DCI and related targets at an early stage in their development. An accurate prediction of DCI
will enable a more proactive strategy to prevent and treat the underlying cause of DCI.
The following three aims will be pursued towards the goal of the project: 1) Develop aSAH-specific
intracranial pressure (ICP) pulse-based cerebral arterial state index; 2) Develop and validate predictive
models of targets related to delayed cerebral ischemia after aSAH; 3) Conduct a prospective institution-
specific adaption and validation of the developed models.
Our DCI predictive algorithms only need data available in current clinical practice hence they can
be readily adopted. If validated, these algorithms will enable clinicians to monitor risk of DCI
continuously and to proactively deliver appropriate treatment. The proposed prospective study of
algorithm implementation and adaptation will well prepare future clinical trials to test the efficacy of
algorithm-informed interventions.

Public health relevance
Project Narrative Delayed cerebral ischemia (DCI) is a devastating complication after aneurysmal subarachnoid hemorrhage (aSAH) and has an incidence rate of 30%. Current practice relies on intermittent assessment of neurological status and daily cerebral blood flow velocity (CBFV) by Transcranial Doppler ultrasound (TCD) to guide medical management to prevent DCI. The goal of this project is to develop algorithms to predict DCI and other related targets at an early stage in their development to enable a more proactive strategy to prevent and treat the underlying cause of DCI.